Genomics and Personalized Medicine

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Genomics and Personalized Medicine, organized by Michael Snyder, Leroy E. Hood and Heidi L. Rehm. The meeting will be held in Banff, Alberta, Canada from February 7-11, 2016. Genomics and other omics technologies are playing an increasingly important role in health care, and new sensors are being developed to help manage personal health. Spurred by the revolution in DNA sequencing technologies, it is now possible to sequence the genome of patients with cancer, undiagnosed disease and even healthy individuals to help tailor treatment for a specific individual's disease. This entire area is moving extremely rapidly in terms of technology, data, its management and analysis, and clinical uptake. The goal of this meeting is to bring together leaders in technology development, basic scientists, engineers and clinicians to advance human health. The conference intends to: 1) Help researchers and clinicians keep abreast of the latest developments; 2) Stimulate collaborations; and 3) Spur the development of new technologies that will improve personalized medicine. Opportunities for interdisciplinary interactions will be significantly enhanced by the concurrent meeting on The Cancer Genome, which will share a keynote address and three plenary sessions with this meeting.

Public health relevance
PUBLIC HEALTH RELEVANCE: The field of genomic technology research is still in its infancy and yet genome sequencing and other technologies (epigenomics) are expected to transform medicine in many ways. These technologies will enable us to better predict disease susceptibility, diagnose diseases early, and are already helping to treat cancer patients and solve undiagnosed diseases of children and adults. The Keystone Symposia meeting on Genomics and Personalized Medicine will be unique in bringing together leading scientists, engineers, computer scientists and clinicians to present their latest work, share ideas and discuss new technologies that are emerging and needed to drive the field forward. By gathering researchers with a spectrum of perspectives on these issues we hope to make a significant contribution to advancing the field and the potential to advance human health.